STUDY OF OCULAR GLIAL CELLS INVOLVEMENT IN UVEITIS

The work concerns uveoretinal inflammatory disease mechanisms. The study focused on evaluating the role of resident cells at the target organ level. Muller cells interactions with T-lymphocyte cell line was studied in vitro. Two opposite effects of Muller cells on T-lymphocytes proliferation were found that could be expressed under different culture conditions. An inhibitory effect on antigen driven poliferation of T-helper lymphocytes could be modulated with various drugs that allowed the Muller cells to function as antigen presenting cells.